ACTL6a ties metabolic reprogramming to cancer stem cell maintenance in oral cavity squamous cell carcinoma

PROJECT SUMMARY
Head and neck squamous cell carcinoma (HNSCC) is a leading cause of cancer mortality and treatment
can cause significant functional impairments for survivors. Despite advances in treatment, survival rates have
not meaningfully improved across many disease sites over the last several decades. Cancer metabolism is
known to play important roles in tumor progression and treatment resistance, and HNSCC tumors undergo
metabolic changes to increase energy production through glycolysis; however, the underlying mechanisms for
this metabolic shift are poorly understood and targeting cancer metabolism remains elusive. The broad research
goal of this proposal is to define how ACTL6A, a gene commonly amplified in HNSCC and a component of the
SWI/SNF chromatin remodeling complex, contributes to metabolic reprogramming in HNSCC. Preliminary work
shows that ACTL6A decreases mitochondrial potential of HNSCC cells and may be necessary for maintenance
of a cancer stem cell like population of cells with low mitochondrial potential. These findings suggest ACTL6A
expression levels may be important for regulating rates of ATP production from oxidative phosphorylation and
glycolysis in cancer cells. To uncover how ACTL6A regulates cell metabolism, Aim 1 will quantify energy
production in settings of low and high ACTL6A levels using HNSCC cells. An additional sub-aim will use an in
vivo tumor model with a cancer drug targeting aerobic respiration along with a drug targeting SWI/SNF to
establish a new strategy for treating HNSCC. Aim 2 will use CUT&RUN to define SWI/SNF distribution of a cell
population with low mitochondrial activity and increased cancer stem cell gene expression whose population is
nearly completely attenuated with ACTL6A knockdown. Together, these aims will establish the role of ACTL6A
on cell metabolism, offer new combinations of therapies that may be effective against HNSCC, and open a novel
area of research into regulation of cancer stem cell metabolism by SWI/SNF.

Public health relevance
PROJECT NARRATIVE Head and neck cancer is the sixth most common cancer worldwide and outcomes remain poor for many patients, with limited treatment gains over the last several decades. Changes in cancer metabolism are common in head and neck cancer but are not exploited for treatment benefit. This proposal studies a gene called ACTL6A to show how it regulates metabolism of head and neck cancers with the goal of developing new treatments.